Anesthesia Care Delivery in Rural America: The Impact of Organizational Climate on Burnout, Job Satisfaction, and Intention to Leave among Certified Registered Nurse Anesthetists

Burnout among Certified Registered Nurse Anesthetists (CRNAs) is a growing public health crisis with recent
estimates as high as 72%. As CRNAs are the predominant anesthesia providers in 80% of rural counties
across the United States (US), and with rural residents notably an Agency for Healthcare Research and Quality
(AHRQ) priority population, mitigating CRNA burnout and preventing its adverse sequalae (i.e., job
dissatisfaction, intention to leave one’s primary position) is critical to ensure an ample supply of CRNAs to
meet the demand for surgical and anesthesia care. A paucity of literature exists exploring organizational
factors contributing to CRNA burnout. Organizational climate (i.e., interprofessional relations, workload,
autonomy, and administrative support) conceptualizes the structural and process factors within an organization
and has been shown to impact burnout, job satisfaction, and intention to leave. However, no study to date has
explored these associations in the CRNA population. CRNAs provide high-quality, equitable, and cost-effective
anesthesia care for rural populations, which makes clear the need to identify organizational factors that support
their wellbeing and retention. The proposed study will investigate, for the first time, the impact of organizational
climate on burnout, job satisfaction, and intention to leave among CRNAs employed in rural settings using a
mixed-methods approach. The project’s specific aims are: Aim 1. To examine whether CRNA organizational
climate (CRNA-Organizational Climate Questionnaire) is associated with burnout (Maslach Burnout
Inventory), job satisfaction (single validated item), and intention to leave (single validated item) among
CRNAs in rural settings. We hypothesize that poor organizational climate will be associated with increased
CRNA burnout, decreased job satisfaction, and increased intention to leave primary position. We will collect
cross-sectional survey data from an estimated sample of 219 CRNAs employed in rural settings in California,
New York, and Texas (to study varying state scope of practice regulations) and build multi-level regression
models to determine associations. Exploratory Aim. Explore whether CRNA organizational climate moderates
the associations between state scope of practice regulations and burnout, job satisfaction, and intention to
leave for CRNAs in rural settings. Aim 2. Understand the CRNA perspectives of organizational climate
factors related to burnout, job satisfaction, and intention to leave in rural settings. We will bolster survey
findings using 1:1 qualitative interviews with 10-16 CRNAs until data saturation is reached. The robust
research infrastructure at Columbia University, coupled with the guidance of an exceptional mentorship team,
experts in rural workforce policy, organizational climate, and multilevel modelling, will provide the support to
achieve these aims. The evidence generated in this proposal, aligned with AHRQ’s mission, may
optimize workforce policy and identify interventions aimed at reducing CRNA burnout and turnover to
ensure access to high-quality, safe, affordable surgical and anesthesia care for rural residents.

Public health relevance
PROJECT NARRATIVE Certified Registered Nurse Anesthetists (CRNAs) are the sole anesthesia providers in 80% of rural counties in the United States. However, CRNA burnout is as high as 72%, yielding an increased intention to leave one’s primary position. This will be the first research project to examine organizational factors impacting CRNA burnout and turnover and to identify interventions aimed at sustaining the supply of high-quality surgical and anesthesia care providers in rural populations.